Leveraging AI to discover neuron-targeted anti-addiction drugs

Project Summary
In this project, we will leverage two artificial intelligence (AI) tools and our company’s unique Historeceptomics
approach to rapidly discover an impactful new drug candidate to treat opioid use disorder (OUD) relapse via
inhibition of withdrawal-associated negative affect (hyperkatifeia). The premise is that, unlike traditional drug
discovery, which is conceptualized starting from drug targets (e.g., mu opioid receptor) and proceeds to
phenotypes (e.g., pain relief), we can select specific cells or tissues that control a specific in vivo phenotype, in
this case hyperkatifeia, and work backward to identify a drug target specific for those cells, followed by the
discovery of a drug-like compound that modulates that drug target. This would be a revolutionary new
paradigm for OUD drug discovery, translating extensive neuroscience knowledge about neural circuits that
elicit specific analgesic, addiction or withdrawal phenotypes directly into drugs, which has not been direct or
efficient before. The critical technical advance that makes this paradigm possible is the capability to screen
virtually for drug candidates targeted at any human gene product. In other words, this drug discovery process
can start agnostic to the eventual target, with confidence that ligands for that target can rapidly be discovered
once it is identified. This advance is made possible by our Historeceptomics technologies, which allow us to
query a specific cell or tissue and identify, with statistical significance, gene products exclusive or maximally
specific to that tissue. The advance is also made temporally feasible by two historic breakthroughs in AI: 1)
AlphaFold2 from DeepMind/Google, which has predicted accurate 3D structures, suitable for virtual chemical
library screening, for every human gene product for the first time in history; and 2) breakthrough AI binding
affinity prediction for drug candidates to 3D structures developed by our partner Molsoft LLC, which uses a
convolutional neural network. We thus aim to 1) adapt our current Historeceptomics Tissue Search software
feature to single cell RNA seq data profiling of the human amygdala and identify gene products exclusive to
Rspo2+ neurons, which control hyperkatifeia. 2) perform an ultra-large virtual library screen using our AI
binding affinity prediction of the 1.5 billion Enamine Real database of drug-like chemical compounds for drug
candidates that bind to the AlphaFold2-generated, manually optimized, 3D structure of the thus-identified gene
product, 3) test validated hit compounds for their ability to reduce the negative affect of protracted opioid
abstinence and relapse in vivo. A drug targeting reinstatement in people suffering from OUD is arguably more
impactful than other anti-addiction approaches, because it could synergize with medication-assisted treatment
(MAT), psychosocial therapies and community-based recovery supports by neurochemically reducing the
impact of triggers conditioned by avoidance of withdrawal symptoms. We will leverage AI to discover such a
drug within three years with modest investment, which would both advertise the paradigm of tissue/cell focused
drug discovery and the power of AI to accelerate drug discovery for OUD/SUD.

Public health relevance
Project Narrative Discovering drugs that treat relapse in substance use disorder is a major challenge. The challenge might be met if novel drugs could be focused in their activity to specific neuronal circuits in the brain, which mediate addiction behavior conditioned negatively by withdrawal. Breakthrough AI tools for computational drug discovery now make such focusing possible, and we will seek proof of principle for this approach in this project.